CORE--DATA MANAGEMENT AND STATISTICAL ANALYSIS

The Data Management and Statistical Analysis Core performs data management and analysis for the Clinical Core, the Neuroimaging Core, for the Neuropathology Core and for individual research projects affiliated with of the ADCC, and maintains all data collected by the ADCC in a centralized database. This facility also provides consultation in the design of experiments and statistical analysis to all collaborating investigators in the ADCC. Investigators have the option of running their own data analyses in consultation with Data Management and Statistical Analysis Core personnel, or having the core personnel provide consultation concerning interpretation of results. The centralization of these functions makes it possible for each of the research projects to benefit from more sophisticated and flexible statistical and computer tools than would normally be available for any one project and fosters sharing of data among collaborating investigators in the ADCC. The centralized database incorporates all the data on subjects who have been evaluated for participation in the ADC and is updated continuously with the results of evaluations of new subjects and longitudinal information about all subjects. Al changes in subjects' mental and physical status, as well as key outcome variables of drug trials, other clinical studies, neurobiological and postmortem studies are recorded. The core has fully achieved and exceeding its original specific aims. A new local area network (LAN) computer system using all new equipment has been installed this year, and is used to implement centralized data management. The database now encompasses not only data gathered since the inception of the ADC but also all data collected prior to establishment of the ADCC in a uniform format with consistent labeling and data codes. A data resource has been achieved that is unique in both size and diversity. Individual investigators at NYU or elsewhere are able to use with the database for exchange and sharing of data, and procedures for sharing data with the NIA-Alzheimer's Disease Data Coordinating Center (ADCC) have been established. Integrating the formation about the behavioral, physiological and psychosocial components of the disorders being studied at the ADCC in one database has made it possible to develop a rich resource for study the normal and abnormal concomitants of aging.